Continuity Supplement: K01 MH127306

PROJECT SUMMARY/ABSTRACT
Adolescence is a particularly important period in social and cognitive development, characterized in part by rapid
increases in exploration, social interaction, and neural connectivity. Social isolation in adolescence has a clear,
profound impact on a wide range of behavioral and physiological endpoints extending into adulthood. The
overarching research goal of this proposal is to elucidate how adolescent social isolation in male and female
mice alters value-based decision making in adulthood, as well as the underlying corticostriatal circuitry driving
these complex goal-directed behaviors. This work is timely and vitally important as COVID-19 has subjected an
increasing number of adolescents to social isolation through school closures and stay-at-home orders.
A first aim of this proposal is to use operant tasks to systematically investigate how adolescent social isolation
impacts how mice later value reward benefits and integrate expected costs during decision making. Preliminary
data suggests that adolescent social isolation amplifies reward value, but specific aspects of decision-making
behavior will be disentangled with computational modeling of value-based choice. The second aim builds on this
behavioral work to test the hypothesis that adolescent social isolation disrupts corticostriatal circuitry and striatal
output during adult value-based decision-making. A distributed neural network is engaged during decision-
making, and the dorsomedial striatum (DMS) is a key node in this network. Prefrontal inputs to the DMS from
the medial prefrontal cortex (mPFC) and orbitofrontal cortex (OFC) are critically involved in action selection and
outcome valuation, respectively. All three of these nodes undergo maturation and refinement during
adolescence, and adolescent social isolation disrupts this development. However, how this impacts adult
corticostriatal function remains unknown. Using in vivo electrophysiology, local field potential (LFP) and single-
unit recordings will be used to test how adolescent social isolation affects synaptic strength and connectivity from
these cortical regions to the DMS during value-based decision-making behavior.
This work proposed in the Mentored Research Scientist Development Award will provide Dr. Elizabeth Holly with
training in computational modeling of decision-making behavior and in vivo electrophysiology, which will be an
important part of the foundation of her independent research career. By completion of this Award, the goal is for
Dr. Holly to transition to a tenure-track faculty position and apply for an R01. The mentorship team Dr. Holly has
assembled will ensure her successful training in these techniques, and prepare her to transition to her own
independent research laboratory.

Public health relevance
PROJECT NARRATIVE Adolescence is an important period in social and cognitive development, and social isolation during this developmental stage has long-lasting impacts on physical and mental health. Value-based decision making, or how we make decisions about the costs and benefits of alternative options, is a crucial aspect of daily life. This project will uncover how adolescent social isolation alters these complex decision-making behaviors in adulthood, as well as the underlying neural circuitry.